Effectivenes, Safety, and Patient Preferences of Infliximab Biosimilar Medications for Inflammatory Bowel Disease

Background: Biologic medications (biologics) are highly effective for diseases of the immune system, cancers, and other conditions; however, their high expense is a barrier to care and a burden to the healthcare system. Biologics cannot be exactly copied as “generic” medications. Biosimilars- similar, but not identical versions of biologic medications- are approved with large potential cost savings. However, VA providers and patients have concerns regarding biosimilar switching safety and effectiveness as disease-specific randomized controlled trials are not required for approval. Significance/Impact: Antagonists to tumor necrosis factor-α (Anti-TNFs) are the largest class of biologics with biosimilars where switching may be feasible to reduce costs; however how to safely and effectively integrate their use in a manner acceptable to patients is unknown. This proposal addresses the VA HSR priority of veteran safety, the ORD-wide research priority of increasing substantial real- world impact of VA research, and uses cross-cutting HSR methods of health systems engineering through a learning healthcare system. Innovation: Crohn’s disease (CD) and ulcerative colitis (UC) are the 1st and 2nd most common indications for Anti-TNFs in the VA and can serve as a model for a learning healthcare system approach for mitigation of adverse events related to biosimilar switching. Specific Aims: Aim 1a: To compare rates of adverse events in CD and UC patients continued on Anti-TNF originator to those switched to biosimilar. Aim 1b: To compare rates of CD or UC exacerbation in patients continued on Anti-TNF originator to those switched to biosimilar. Aim 2: To compare the accuracy and calibration of 2a) traditional regression models vs. 2b) machine learning models for predicting medication related adverse event related to Anti-TNF in VA users with CD and UC. Aim 3: To use deliberative democracy methods to engage Veterans, to elicit their preference regarding ?like medication switch programs with and without their knowledge and to develop consensus around treatment approaches. Methodology: Aim 1 will be achieved through a retrospective cohort study of CD and UC patients who received Anti-TNF from the national VA datasets from 2017-2019. Adverse events and exacerbations will be determined using a combination of administrative data and manual chart review. Analyses for Aim 1 will proceed by Poisson regression using GEE. Adjusted event rate ratios of patients switched to biosimilar compared to those who continued on originator biosimilar will be calculated with 95% confidence intervals and Wald p-values will be derived from the regression model estimates. Prediction of patients who have adverse events to Anti-TNF will inform selection of appropriate therapy, and guidance of patients for biosimilar switching. For Aim 2, both traditional regression models and machine learning models will be constructed to identify which model will be better for predicting Anti-TNF related adverse events. Developing the best possible risk stratification tool by comparing these models will allow us to identify veterans that are at risk of adverse events to improve both the quality and efficiency of veteran care. It is critically important that VA policies incorporate the opinions of Veterans on ethically controversial issues that impact their health. Aim 3 will employ deliberative democratic methods that offer a practical and reliable approach to soliciting informed and considered opinions in complex policy issues. Democratic deliberation uses education by experts and carefully structured deliberation among peers to deliver informed opinions and policy suggestions from concerned stakeholders. Next Steps/ Implementation: This proposal is supported with clinical partners: the national VA Inflammatory Bowel Disease Technical Advisory Group and Pharmacy Benefits Management who will disseminate findings from this study through VA-specific biosimilar switch clinical guidelines and VA-pharmacy prescription policy. Future studies will include pragmatic clinical trials of other biosimilar biologics using the learning healthcare platform created in this proposal.

Public health relevance
The class of biologic medications are highly effective, yet highly expensive medications. Biologics are different from standard medications because they can only be created using living systems, and are therefore cannot be exactly copied as a “generic” medication. Biologics are among the fastest growing class of medications and are used for diseases of the immune system, cancers, and other conditions. Biosimilars are copy versions of biologic medications and have recently been approved for use in immune conditions. Biosimilars for immune conditions have been shown in early studies to have similar efficacy as original biologics and are available at a significantly cheaper cost. However, many patients and providers have concerns regarding the safety and effectiveness of biosimilar switching as they are not identical. This proposal aims to use a learning healthcare systems approach to study the safety, effectiveness, and Veterans’ views of acceptance of biosimilar switching.